Substance Use Prevention for Recently displaced Adults (SUPRA)

PROJECT SUMMARY
The war in Ukraine has provoked the world’s current largest humanitarian displacement: since February 2022,
over 13 million people, i.e., one-third of Ukrainians, have been forced to leave their homes, resulting in nearly 6
million internally displaced persons (IDPs). War and humanitarian emergencies may exacerbate substance
use, but the incidence and prevalence of unhealthy substance use in humanitarian settings, including Ukraine,
are currently largely unknown. This lack of data limits the ability to tailor targeted, effective preventive
substance use interventions for these mobile populations. Addressing this knowledge gap is an immense
priority for Ukraine, where rates of substance use were high even prior to the Russian invasion in February
2022, and in other settings hosting large populations of IDPs, including the United States. We propose to
conduct an epidemiological substance use survey among IDPs in Ukraine during the R61 phase, followed by
R33-supported development and evaluation in a randomized controlled trial of a substance use prevention
intervention for this population. Due to burgeoning evidence and our own preliminary data, we anticipate
adapting an Acceptance and Commitment Therapy (ACT)-informed intervention, though final intervention
decisions will be responsive to the needs identified in the epidemiological phase. ACT for substance use
prevention will use acceptance, mindfulness, and behavior change processes to improve psychological
flexibility and thus support people in refraining from use. Our transnational, multidisciplinary team of community
partners, mental health experts, and behavioral clinical trial scientists has conducted studies with war-affected
populations in Ukraine and successfully used ACT to improve health behaviors among disadvantaged
populations in Eastern Europe. We will work closely with our community partner, the Alliance for Public Health
(“Alliance,” a leading non-governmental organization in Ukraine) and academic experts in Ukraine. In the R61
phase of the grant, we will conduct an epidemiological survey (n=577) evaluating substance use patterns and
risk factors among IDPs seeking medical services at mobile medical points established by the Alliance. Directly
informed by findings from the epidemiology study, we will transition to the R33 phase and will engage
community members to co-design the most appropriate prevention intervention. We will adapt the intervention
using qualitative methods (focus groups and stakeholder interviews) and conduct a pilot randomized controlled
trial (n=144) evaluating the intervention on preventing the development of substance use disorders among
IDPs, with primary outcomes including feasibility and acceptability. The expected outcome of this award is a
potentially effective and scalable intervention that could prevent at scale the development of substance use
disorders among IDPs affected by humanitarian crises. The key innovation is that this study will expand on
limited epidemiological data specific to substance use in humanitarian settings and be among the first to
demonstrate the effectiveness of an intervention to prevent substance use disorders in humanitarian contexts.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is aimed at 1) increasing knowledge of the impacts of exposure to humanitarian emergencies on substance use and the development of substance use disorders and 2) informing methods of preventing substance use disorders among people affected by humanitarian emergencies. This project will evaluate the prevalence of substance use among internally displaced persons in Ukraine and adapt a substance use prevention intervention, likely Acceptance and Commitment Therapy-based sessions, specifically for use among this population. The proposed research is directly relevant to NIDA’s 2022-2026 Strategic Plan for Research via its focus on testing innovative approaches to prevent substance use disorders in real-world settings and has specific relevance for domestic populations in the United States, particularly the rising numbers of refugees and other individuals migrating due to the increasing number of global humanitarian crises.